Involving Family to Improve Advance Care Planning for Primary Care Patients with ADRD

PROJECT SUMMARY
Alzheimer's Disease and Related Dementias (ADRD) are among the most profoundly disabling and costly of all
health conditions and the 5th leading cause of death. Family caregivers are at the forefront of managing ADRD
across the continuum of care but are not routinely included in discussions about prognosis and are often poorly
prepared to engage in surrogate decision-making. Compared to older adults without ADRD, those with ADRD
are less likely to complete an advance directive and to formally designate a surrogate decision-maker, and are
at heightened risk for unnecessary suffering and burdensome end-of-life care. Advance care planning seeks
to improve communication about individual values, goals, and preference for care, but typically targets a
specific decision, most often in the inpatient hospital or nursing home. Few interventions target advance care
planning in primary care, which is where most persons with ADRD are initially diagnosed and medically
managed. We propose a developmental study of a multicomponent communication intervention, referred to as
SHARE, to proactively engage family caregivers and support advance care planning in primary care.
Intervention components include: 1.) a letter from the primary care practice introducing a new advance care
planning initiative, 2.) person-family agenda-setting to align patient and family perspectives regarding the role
of the family member in primary care interactions and stimulate interest in advance care planning, 3.) ongoing
access to a nurse or social worker trained to lead advance care planning conversations, 4.) facilitated
registration for the patient portal (for patient and family) to enable and extend electronic interactions and
information access to family caregivers. Study Aims reflect two phases that aligned with Stage 1A (refinement)
and Stage 1B (testing) of the NIH behavioral intervention development Stage Model. First, we use a user-
centered process to refine SHARE with input from primary care stakeholders (physicians, nurse practitioners,
social workers, staff), patients with ADRD, and their family caregivers. We will iteratively adapt and pre-test
the protocol in 10-15 patient-caregiver dyads at 1 primary care practice. Aim 1 will yield a testable intervention
protocol. Second, we will partner with 4 primary care practices to conduct a two-group randomized Stage 1B
trial in which 124 dyads receive a control protocol of usual care and 124 dyads receive the intervention
protocol. We hypothesize that intervention (versus control) family caregivers will report better quality of
communication at 6 months (primary outcome) and among patients who die, that intervention (versus control)
patients will experience higher quality end-of-life care and bereaved family caregivers will be better prepared
for surrogate decision-making and report fewer symptoms of anxiety and depression (secondary outcomes).
We will qualitatively assess the implementation context to identify factors that may affect dissemination of the
intervention. Aim 2 will provide critical information and evidence to facilitate subsequent dissemination.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's Disease and Related Dementias (ADRD) are the 5th leading cause of death. Persons with ADRD are less likely to complete an advance directive than those who do not have ADRD. Little attention has been directed at interventions to improve advance care planning in primary care, which is where most persons with ADRD are initially diagnosed and medically managed. This study will refine and test the efficacy of an advance care planning intervention among persons with ADRD through proactive engagement of families in primary care.